Enhancing robotic head and neck surgical skills using stimulated simulation

Enhancing robotic head and neck surgical skills using stimulated simulation
Abstract
We propose stimulated simulation as the next paradigm for accelerating simulator-based training of
transoral robotic surgery (TORS) using noninvasive brain stimulation. TORS is a minimally invasive
technology that is seeing rapid adoption in the field of otolaryngology - head and neck surgery to resect
benign and malignant tumors of the pharynx and larynx as well as treat obstructive sleep apnea. As a relatively
novel and complex procedure, surgeons are learning to perform TORS after their residency, mostly during a
fellowship year. However, TORS has a steep learning curve, with a minimum of 20-35 cases needed to
achieve basic proficiency. Without a structured curriculum or effective simulation platform, most novice
surgeons currently reach the 20-35 case benchmark while operating on live patients. Consequently, positive
margin (i.e., the tumor is not entirely removed) rates for oropharyngeal cancers in low-volume centers are
twice that in high-volume facilities. Commercially available task trainers and virtual reality simulators for robotic
surgery have four major deficiencies: (i) they do not prepare trainees to operate in the confined space of the
oropharynx and do not provide the procedure-specific skills necessary for TORS, such as tissue manipulation,
retraction, or dissection using electrocautery; (ii) they are platform-dependent – training basic robotic skills for
the da Vinci platform (Intuitive Surgical, Sunnyvale, CA), though two platforms are currently FDA approved for
TORS, and a third one is waiting for approval, (iii) they are costly, limiting their use to the most affluent centers
and (iv) they offer no mechanism to accelerate skill acquisition beyond brute-force repeated practice.
To address these limitations, we will design, develop, and validate the first Virtual Transoral Robotic
Surgical (VTORS) simulator for training TORS procedures and use transcranial direct current
stimulation (tDCS), a safe and effective, well-established, commercially available, wearable noninvasive brain
stimulation technique that uses very low direct current (<4mA) applied to the scalp to modulate cortical
excitability, to accelerate the surgical skill acquisition. We have assembled a highly interdisciplinary team of
researchers to accomplish the two aims of the project: (SA1) Design, develop and validate a high-resolution,
ultra-low-cost, versatile, and platform-independent Virtual Transoral Robotic Surgical (VTORS) simulator for
TORS tongue base resection; and (SA2) Demonstrate the training efficiency with transcranial direct current
stimulation (tDCS) (i.e., stimulated simulation) compared with sham stimulation.
Based on the latest developments in off-the-shelf virtual reality (VR) and tDCS technology and open-
source simulation software, stimulated simulation has the potential to become the preferred training
paradigm – simultaneously improving skills and accelerating skill acquisition - for complex psychomotor skills,
including surgery, aviation, driving, sports, and music.

Public health relevance
Relevance: This research aims to develop and validate a technology that will help medical trainees practice their skills using afforable and widely available head-mounted displays for an emerging minimally-invasive procedure for robotic head and neck surgeries. A well-established and safe commercially available neurostimulation device will be used to help the trainees improve their performance. The proposed stimulated simulation training methodology will allow clinicians to learn the procedure in a risk-free manner on computers before application to patients, resulting in lower errors, improved patient outcomes, and reduced treatment costs.